Community-Led Health Impact Project (CLIP)

1.- Modified Project Summary/Abstract Section

Community-Led Health Impact Project (CLIP)

Over 38 million Americans live with type 2 diabetes and more than 122 million have hypertension. Asian Americans face elevated risks for both conditions despite relatively low obesity rates. Our community needs assessment identified 22% diabetes, 25% pre-diabetes, and 57% hypertension, with earlier onset and a high proportion of undetected cases, underscoring the urgent need for prevention and early intervention. The Community-Led Health Impact Project (CLIP) addresses these challenges through a community-driven, multilevel strategy guided by Health Excellence Research Assembly (HeRA) and its Community Advisory Board (CAB). Guided by the Socio-Ecological Model, CLIP integrates two complementary strategies: Culturally Tailored Food as Medicine (CFAM) and Digital Health Solutions (DHS). CFAM incorporates culturally familiar foods into nutrition education, prescriptions, and chronic disease prevention, delivered through trusted community-based organizations and supported by CHWs who provide counseling, referrals, and care navigation. DHS enhances access to multilingual health information, digital self-monitoring tools, provider training, and linkages to health and social services. Aim 1 Develop and conduct a pilot intervention to evaluate the feasibility, acceptability, usability, and preliminary efficacy of the CLIP multilevel Food as Medicine (FAM) intervention delivered through community-based organizations (CBOs), supported by community health workers (CHWs), and enhanced with culturally responsive digital tools. Aim 2 will evaluate preliminary effects from baseline to 6 months. Primary outcomes include CFAM prescription uptake and digital health literacy. Secondary outcomes include improvements in social determinants of health (healthy food access, resource connection, navigation support), behavioral risk factors (dietary behaviors, diabetes risk scores, self-monitoring of glucose and blood pressure), and clinical indicators (blood pressure, HbA1c, weight, BMI). This program will be implemented across Greater Philadelphia, New Jersey, New York City, and Washington DC (DMV) region. Findings will inform refinement, scalability, and sustainability of a culturally grounded, digitally enabled Food as Medicine model designed to reduce diabetes and hypertension disparities nationwide.

Public health relevance
3. Modified Public Health Relevance Section The overall goal of CLIP is to strengthen chronic disease prevention by addressing food-related social determinants of health through a multilevel Food as Medicine (FAM) intervention. The model integrates culturally responsive nutrition support, community health worker (CHW) engagement, and a digital health platform to expand access to healthy foods, strengthen nutrition and digital health literacy, and enhance self-management of diabetes and hypertension risk. Implemented across Greater Philadelphia, New Jersey, New York City, and the Washington, D.C. (DMV) region, CLIP aims to reduce cardiometabolic risk and establish a scalable, community-driven model for improving population health outcomes.